NATIONAL HEART, LUNG, AND BLOOD INSTITUTE (NHLBI) ENTERPRISE RISK MANAGEMENT (ERM) PROGRAM TASKS A & B

Provide subject matter expert assessments of NHLBI’s Assessment and Authorization and IT Controls processes confirming NHLBI’s Risk Management Framework approach is applied, employing National Institute of Standards and Technology standards. Identify system-specific gaps, and program-wide deficiencies, issuing corrective action plans to inform programmatic improvements based on trends and findings across systems.